Biomolecular Mass Spectrometry Core

BIOMOLECULAR MASS SPECTROMETRY CORE (BMSC): ABSTRACT
The Biomolecular Mass Spectrometry Core (BMSC) is a key component of exposure assessment
in the Center of Excellence in Environmental Toxicology (CEET) described in the Strategic
Vision. The mission of the Core is to foster the use of biomolecular mass spectrometry to
measure reporters of the exposome, (e.g., proteome, lipidome, metabolome and adductome) as
biomarkers of exposure, adverse response, outcome and therapeutic response for diseases of
environmental etiology. It performs work in cell-culture based models, in animal models and
patient cohort studies designed in the Translational Research Support Core (TRSC). The BMSC
recognizes the need to relate phenotypic changes in biomarkers with either changes in the
transcriptome or with genetic variants and this is achieved by data integration performed by the
Environmental Health Informatics Core (EHIC). The integration of genomic data and reporters of
exposomic biomarkers offers the promise to deliver multi-omics approaches to diagnosis and
prognosis. The BMSC is equipped with state-of-the-art ultraperformance liquid chromatography
(UPLC)-MS and UPLC-high resolution (HR) MS instrumentation. It is also equipped with an ionchromatography
system coupled to inductively coupled plasma (ICP)-MS for heavy metal analysis
with speciation. In the Core untargeted approaches are followed by targeted LC-MS assays. Our
targeted LC-MS assays use stable-isotope dilution (SID) LC-MS as the gold standard for precision
and accuracy; many of the assays cannot be performed elsewhere in the world. The BMSC will
achieve the CEET mission under the following aims: Aim 1: We will support the CEET thematic
areas (Air Pollution & Lung Health; Environmental Exposures & Cancer; Windows-of-
Susceptibility; and Environmental Neuroscience) and the cross-cutting theme of the effects of
extreme weather on health with high-throughput services and facilitate biomarker discovery using
Exposomics approaches (proteomics, lipidomics, metabolomics and adductomics). We will also
support large multi-investigator grant applications, transcending CEET thematic areas. Aim 2:
We will provide CEET investigators with highly sensitive and specific assays to quantify
biomarkers of exposure and effect in model systems and in biofluids from population cohorts and
patients. Aim 3: We will develop new assays for the thematic areas and prioritize services based
on the needs of CEET investigators. Aim 4: We will provide analytical support for pilot project
recipients, for preliminary studies in environmental health sciences and provide support for
adjunct faculty with NIEHS funding from other universities in our area and from other
Environmental Health Sciences Core Centers (EHS CCs) that do not have access to our assays.
Aim 5: We will provide access and training to use state-of-the-art analytical equipment and
software, for CEET investigators and their trainees, through monthly training sessions and annual
workshops.